Validation of Critical 1q21 Vulnerabilities in Multiple Myeloma

PROJECT SUMMARY
Amplification of 1q21 defines one of the most common multiple myeloma (MM) subtypes with an adverse
prognosis. The 1q21 amplicon contains many genes, and while it is unlikely that all contribute to the
pathobiology of high-risk MM, the critical genes that do drive this high-risk phenotype have not yet been fully
clarified. Identifying such genes and their contributions to this phenotype would enable the development of new
and effective targeted therapy strategies for high-risk MM and thus improve their survival outcomes. In this
application, we propose to investigate the biological and molecular mechanisms behind the 1q21
amplification's contribution to high-risk MM with the ultimate goal of obtaining a list of validated therapeutic
targets to inform the design of novel translational clinical trials for this subgroup of patients. In preliminary
functional genomic studies, we identified five 1q21 essential genes whose loss results in MM cell death and/or
growth inhibition. Our initial mechanistic studies of one of these genes, ILF2 (interleukin enhancer binding
factor 2), suggest that the gene is involved in the regulation of the DNA damage response and mediates drug
resistance to genotoxic agents in a dose-dependent manner, which may explain why 1q21 MM patients benefit
less from high-dose chemotherapy than non–1q21 MM patients do. On the basis of these data, we hypothesize
that the five 1q21 gene candidates we have identified make essential contributions to the high-risk MM
phenotype and that the preclinical validation of these critical 1q21 vulnerabilities will yield novel therapeutic
targets for these patients. To test these hypotheses, we will pursue the following three specific aims: 1) To
dissect the molecular mechanisms underlying 1q21 gene candidates' contributions to the high-risk MM
phenotype, we will subject these candidates to in vitro functional validation studies using a panel of
genomically characterized human MM cell lines, primary MM samples, and xenograft models. 2) To identify
1q21 gene candidates' roles in MM pathogenesis in vivo, we will employ a novel, physiologically relevant
genetic approach that targets these genes' expression in the germinal center cells, considered to be the cell-of-
origin of MM plasma cells. 3) To determine the feasibility of therapeutically targeting ILF2, we will
collaborate with IONIS Pharmaceuticals to develop antisense oligonucleotides targeting ILF2 and functionally
validate their effectiveness both alone and in combination with DNA-damaging agents in inhibiting MM
growth/progression in preclinical xenograft mouse models of disseminated MM. We anticipate that the
proposed study will not only expand our understanding of 1q21 genes' contributions to MM pathobiology but
also inform the development of new targeted approaches to improve the outcomes of MM patients who have
high-risk disease that is refractory to our approved therapeutic agents.

Public health relevance
PROJECT NARRATIVE The proposed research addresses a fundamental disparity in the outcomes of standard-risk and high-risk multiple myeloma (MM) patients. Successful completion of this research effort will expand basic knowledge of the molecular mechanisms responsible for the high-risk 1q21 MM phenotype, validate novel approaches targeting this lesion, and translate these approaches to the clinic to improve outcomes for high-risk MM patients and, given the frequency of the 1q21 amplification, ultimately other cancer patients as well.